Functional Characterization and Development of Therapeutic Paradigms for DNA Damage Repair (DDR)-deficient Lethal Prostate Cancer

PROJECT SUMMARY/ABSTRACT
The overarching scientific premise of our parent grant is to thoroughly investigate the impact of BRCA2 and DNA
damage repair (DDR) gene alterations on the progression of lethal, untreatable prostate cancer. Our aim is to
identify and develop innovative combination treatments, such as targeted immunotherapy and radiotherapy for
BRCA2 deficient prostate cancer patients. However, the impact of alterations in non-BRCA2 HRR genes on
mCRPC progression is not well understood. In the proposed supplemental project, we aim to elucidate the
molecular mechanisms underlying the impact of non-BRCA2 DDR alteration on mCRPC progression.
We will use CRISPR to generate isogenic pairs of prostate cells and organoids by individually eliminating 14
non-BRCA2 DDR genes. We will perform knockout efficiency and assess the impact of individual non-BRCA2
DDR genes on HRR alteration using Sanger sequencing and DNA damage assays, respectively. Using these
models, we will evaluate whether the loss or elimination of any of these non-BRCA2 DDR genes can effectively
promote castration-resistant prostate cancer progression. Transcriptomic analysis from the isogenic pairs of cells
will help us discover targetable signaling pathways and develop novel therapeutics for lethal prostate cancer.
Recent studies have also highlighted that inhibiting the androgen receptor (AR), such as with enzalutamide,
increases the risk of DNA damage by disrupting the protective effects of androgens on genomic stability. Our
team presented the first report of the loss of KDM5D, a chromosome Y histone demethylase and androgen
receptor (AR) interacting protein, which augments prostate tumor growth and castration resistance. We also
showed that the loss of KDM5D leads to replication stress due to impaired DNA damage repair. We aim to
investigate the molecular mechanisms underlying the AR-KDM5D pathway-mediated DNA damage repair, which
contributes to the progression of prostate cancer to a lethal state.
Our research has identified that the loss of KDM5D leads to the activation of ATR, a pivotal DNA damage sensor
gene. Based on this finding, our study aims to explore the effects of combining AR inhibitors with ATR inhibitors
on the progression of prostate cancer, particularly in cases where KDM5D is lost.
This proposal presents a unique opportunity for mentorship and training in functional genomics, molecular
biology, and prostate cancer research. It offers the candidate valuable career development prospects.
Additionally, the project allows the candidate to utilize extensive experimental model systems and access unique
resources from the parent grant. These resources are essential for addressing the significant research gap
regarding the molecular mechanisms underlying DDR deficiency-induced lethal therapy resistance in the
progression of prostate cancer. Ultimately, this research aims to identify novel therapeutic targets for combatting
this deadly disease.

Public health relevance
PROJECT NARRATIVE Deleterious mutations of DNA damage repair (DDR) genes associated with increased prostate cancer risk and mortality. However, our knowledge of the complete implications of DDR aberrations other than BRCA2 in prostate cancer tissue is limited due to functional significance gaps. This proposal introduces a novel approach to uncover the critical role of non-BRCA2 DDR gene alterations in prostate cancer biology, aiming to enhance treatment strategies.